Longitudinal effects of prenatal cannabis and tobacco co-exposure and postnatal adversity on child regulation: The buffering role of sensitive parenting

PROJECT SUMMARY/ABSTRACT
The current proposal is a secondary analysis of a multi-method, multi-timepoint longitudinal study examining
developmental trajectories of autonomic reactivity and regulation with rich, multi-method assessments of
prenatal cannabis and tobacco exposure. There is a large body of research that implicates prenatal tobacco
exposure (PTE) as a risk factor for negative developmental outcomes. Relatively little research has examined
the impact of prenatal co-exposure to tobacco and cannabis (PTCE), despite increasing rates of cannabis use
and co-use with tobacco among pregnant persons. Preliminary findings indicate that co-exposure has a greater
impact on underlying regulation than tobacco exposure alone. One important regulatory system is the
parasympathetic nervous system (PNS), a branch of the autonomic nervous system that regulates body
function. Our major goal is to examine the role of PTE, PTCE, and postnatal adversity in PNS functioning from
infancy to early school age and examine the potential protective role of early sensitive parenting. The specific
aims of this application are to 1) Examine change in PNS functioning across infancy to early school age; 2)
Examine associations between prenatal substance exposure, postnatal adversity, and PNS functioning across
time; and 3) Evaluate early sensitive parenting as a moderator. The sample consists of 247 caregiver-infant
dyads (51% of mothers identified as Black, 31% White, 19% Hispanic, and 8% more than one race or other
race/ethnicity) from low-income backgrounds who were recruited in the first trimester of pregnancy into one of
three groups: PTE (n = 81, 58.02% male), PTCE (n = 97, 52.58% male), and demographically similar non-
exposed dyads (n = 69, 47.83% male). Substance exposure was measured using calendar-based interviews,
oral fluid assays, and infant meconium at delivery. PNS functioning was assessed during rest and in response
to frustration at 9- and 16- months and at early school age. Postnatal adversity, a composite of maternal mood,
stress, postnatal substance exposure, and the home environment was assessed at every time point. Sensitive
parenting was measured during caregiver-child play interactions at 9- and 16-months and at early school age.
To examine the study aims, a Random Intercept-Cross Lagged Panel Model (RI-CLPM) will disaggregate the
within- and between-person variance in PNS functioning. Prenatal exposure group, early adversity, and
moderation analyses with early sensitive parenting will be evaluated in the RI-CLPM. Exploratory analyses will
use person-centered analyses to examine classes of PNS functioning trajectories, dose-response associations
using continuous measures of exposure and fetal exposure via infant meconium, and the role of specific types
of adversity. This study addresses several gaps in the literature including examination of prenatal co-exposure
using multiple methods and evaluation of changes in PNS functioning over time in a sample experiencing high
pre-to-postnatal adversities. Results will inform both timing and content of preventive interventions beyond
substance use treatment for pregnant individuals.

Public health relevance
PROJECT NARRATIVE The parasympathetic nervous system (PNS), a regulatory system that underlies multiple mental health outcomes, changes across early childhood, and is particularly malleable for children experiencing high levels of pre- and post-natal adversity. Prenatal co-exposure to cannabis and tobacco is increasingly common, is particularly concerning given increased potency of cannabis, and is a teratogen that may impact the PNS, with initial work indicating that the impact of co-exposure may be twice as large as the effect of tobacco alone. The proposed study will evaluate how prenatal tobacco exposure, co-exposure, and postnatal adversity impact individual differences and change in PNS functioning from infancy to early school age and will test the role of early sensitive parenting, a modifiable target for preventative interventions that may reduce the impact of substance exposure.